Fluorescent Redox Indicators to Image Oxidative Stress in Alzheimer's Disease

Abstract
Alzheimer's disease (AD) and other age-related neurodegenerative disorders have become a global health and
social challenge. Although the exact cause of AD is still under investigation, among various AD hypotheses,
oxidative stress is considered either a causative factor or a critical cofactor in cascades of events leading to neuron
death. Because of the importance of oxidative stress in the etiology and pathogenesis of AD, research tools that
can conveniently evaluate oxidative stress in AD models are expected to greatly catalyze and accelerate research
on AD.
The overall objective of this R01 project is to develop and optimize genetically encoded fluorescent redox
indicators (GERIs) for the convenient evaluation of oxidative stress in AD mouse models. This project uses the
synergy of two productive investigators at the University of Virginia (UVA). Huiwang Ai (Ph.D., PI) has expertise
in genetically encoded fluorescent indicators and fluorescence imaging of redox signaling in live cells and animals.
Heather Ferris (M.D./Ph.D., Co-I) is a physician-scientist with a research focus on metabolic drivers in AD and
other cognitive disorders. Leveraging our complementary expertise and strong preliminary results, we will
develop and optimize GERIs for intensity-based ratiometric (Aim 1) and lifetime (Aim 2) imaging. We
hypothesize that the GERIs can be used to conveniently assess oxidative stress status in AD mouse models during
disease progression and in response to therapies, and we will test this hypothesis in Aim 3.
The proposed research will lead to a toolbox of GERIs for quantitative imaging of oxidative stress in
animal models. These innovative tools will allow precise measurement of specific redox parameters in specific
cell types and subcellular domains, facilitating our understanding of AD mechanisms and further intervention
development. Although the focus of the current phase of this project is on technology development and validation,
we expect our study will catalyze an extensive array of biological studies on ROS and oxidative stress in the brain,
resulting in a tremendous amplification of the impact of this project.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Oxidative stress plays critical roles in the etiology and pathogenesis of Alzheimer's and other neurological diseases, such as epilepsy, Parkinson's, and Huntington's. This project will develop a new capability of imaging oxidative stress status in mouse models during disease progression and in response to therapies. This new capability will pave the way for an extensive array of mechanistic studies and intervention development.